Administration

PROJECT SUMMARY—Administration (Core A)
The overarching goal of this PPG has been to detail the cognitive, emotional, behavioral, imaging, pathologic,
and genetic features of the frontotemporal dementias (FTD). We will now translate these findings into usable
clinical tools to accelerate progress in the era of therapeutic discovery. In this renewal, the Administration
(Admin) Core will be separate from the Clinical Core in order to maintain operational efficiency and seamless
synergy between the seven cores and four projects, while allowing the Clinical Core to focus on recruiting,
evaluating, and maintaining a large longitudinal patient cohort. The Admin Core will provide critical management
and quality control that will assure efficiency, productivity, and adherence to University and NIH policies and
regulations. The aims of the Admin Core are to provide the administrative infrastructure necessary for this PPG
to continue to shape the landscape of FTD research that will be invaluable for researchers, scientists, and
clinicians and that will be critically important in shaping and informing future clinical trials. To accomplish our
goals, we propose the following aims and activities: Aim 1: Provide infrastructure to facilitate communication,
integration, and data sharing between PPG cores and projects and scientific collaborators. The Admin Core will
oversee the integration of all cores and projects with special attention to incorporating the new Biospecimens
Core G and the four Projects. Aim 1.a. Ensure clear communication and accountability across the cores and
projects through meetings and web-based management tools and manuals. Aim 1.b. Ensure timely review of
resource requests and secure data sharing. Aim 2: Apply operational management and ensure the scientific,
ethical, and financial integrity of all PPG activities. The core will assure compliance with all applicable laws and
regulations, NIH reporting practices, and human protections standards, giving special consideration to the
vulnerability of people living with dementia and their family caregivers. Aim 2.a. Provide clinical and staff
management, ensure protection of human subjects, and resolve potential challenges and disagreements. Aim
2.b. Manage and provide quality assurance related to financial transactions and NIH reporting. Aim 3: Foster
dissemination of findings, provide mentorship, and monitor inclusion of underrepresented populations into our
staff and research cohorts. This core will leverage traditional academic communication as well as social media
platforms and public-facing events to increase awareness of dementia. We will also promote leadership transition
and foster diversity and inclusion. Aim 3a. Disseminate research findings through media and community activities
to increase awareness and reduce the stigma associated with FTD. Aim 3.b. Mentor new research, clinical, and
administrative leaders, including those from underrepresented groups. Aim 3c. Monitor PPG outreach efforts to
foster inclusion of underrepresented groups in our staff and participant cohorts.